Diabetes: Many Faces of the Disease

ABSTRACT Support is requested for a Keystone Symposia conference entitled Diabetes: Many Faces of the Disease, organized by Drs. Lori Sussel, Juleen R. Zierath and Laura C. Alonso. The conference will be held in British Columbia, Canada from January 29- February 2, 2021. Diabetes continues to be a growing health problem throughout the world; the incidence of both type 1 diabetes (T1D) or type 2 diabetes (T2D) has steadily been rising. However, with the advent of novel technologies, high throughput sequencing, and clinical studies involving diverse human populations, there also has been a growing appreciation for the existence of sub-classifications of both T1D and T2D based on genetics and environmental influences. Understanding and characterizing the different diseases is critical to develop more effective personalized therapies. Therefore, the goal of this conference is to highlight traditional and novel aspects of diabetes research. This program will include lectures on atypical forms of T1D, as well as the emerging premise that beta cell dysfunction contributes to progression of this autoimmune disease. A dedicated session for T2D will highlight disease variations and challenge the current dogma associated with genetic and environmental differences between individuals. This conference is being held jointly with Obesity: From Cell to Patient. The program contains joint sessions, workshops, and even a joint Keynote speaker. The joint sessions will highlight the contribution of obesity to T2D pathogenesis, with an emphasis on novel areas of research, including the role of different types and sources of fat, exosome signaling and the role of the microbiome. Overall, this conference strives to raise awareness in the clinical and basic research communities about the need to sub-stratify diabetes to develop better treatment options.

Public health relevance
PROJECT NARRATIVE Advances in research in the diabetic population have highlighted the fact that Type 1 and Type 2 diabetes are different diseases with distinct etiologies which present both challenges and opportunities in terms of diagnosis and treatments for patients. Therefore, this conference will highlight these challenges by inviting speakers with diverse areas of expertise across diabetes research. Bringing this diversity of people together will inform our growing understanding of different diabetes etiologies and the development of novel therapies and improved allocation of existing therapies to take a more personalized approach to treating diabetes by targeting the appropriate dysfunctional disease pathways.